IDRN-Intergenerational Diabetes Research via Home Visiting Networks

PROJECT SUMMARY/ABSTRACT – IDRN-Intergenerational Diabetes Research via Home Visiting Networks
The primary goal of the Intergenerational Diabetes Research via Home Visiting Networks: National Resource Core (IDRN) is to help Washington University Center for Diabetes Translation Research (Center) investigators translate research into transformative solutions that prevent the familial transmission of type 2 diabetes and improve population health. IDRN is the central hub for conducting diabetes-related parent-to-child research in real-world settings. It is located within the Parents As Teachers National Center (PATNC) in St. Louis, MO. The IDRN team leverages a nearly 30-year academic-community research partnership, working together on numerous NIH-funded studies designed to break the generational cycle of diabetes by engaging families and communities. IDRN provides access to a network of over 2,200 home visiting sites across all 50 states, engaging over 200,000 parents and their children, and maintains extensive administrative and organizational databases to support research efforts aimed at disrupting and preventing diabetes. Core innovations include: (1) unique access to a robust infrastructure that ensures broad and sustainable research engagement with parents, their young children, community members, and multisectoral partners across the country; (2) the team's science- and practice-based expertise, which focuses on real-world implementation and scalable impact of interventions across the PATNC network, an innovative model for diabetes translation research; and (3) the Core's focus on addressing a significant scientific gap by expanding population research to disrupt diabetes patterns, promising to improve health outcomes for current and future generations. IDRN will continue to promote intergenerational diabetes research by providing a national data infrastructure and partner sites to support innovative, real-world interventions. These efforts aim to prevent the familial transmission of type 2 diabetes and improve health outcomes for populations with a high diabetes burden, maximizing both innovation and impact